In Vitro Selection of Proteins via mRNA-Protein Fusions

One of the most challenging problems in molecular design is developing molecules that can bind protein surfaces and block protein-protein interactions. The ability to modulate protein-protein interactions in a directed fashion opens the possibility of probing and controlling biological systems through design. The long- term objective of this proposal is to use in vitro selection experiments to target protein surfaces, exploring fundamental aspects of protein recognition, structure, function, specificity, and catalysis. In vitro genetic approaches currently represent a powerful operational solution to the protein design problem. Previously, the PI has conceived, developed, and implemented mRNA- peptide and protein fusions (hereafter "mRNA display) to design proteins using in vitro selection experiments. mRNA display provides important advantages relative to other in vitro and in vivo protein design strategies, such as the ability to examine very large libraries (>1013 individual sequences) in the absence of a living cell, with tight experimental control over binding and stringency. In this proposal, we will continue using G-protein linked signaling as a target for ligand design. Our goal is to explore the biophysical chemistry of protein recognition as it pertains to this important signaling pathway. Our specific aims are: 1) To enhance the properties of our G protein and GPCR-directed ligands. 2) To develop peptide and protein ligands targeting the 2-adrenergic (2AR) G protein coupled receptor (GPCR). 3) To explore the function and structure of our GPCR-directed ligands.

Public health relevance
Long-Term Health Relevance The molecules and understanding resulting from our work have the potential to directly impact human health. G proteins and G protein-coupled receptors play central roles in cell signaling. These molecules are also critical in the normal function of the immune system and disease processes including cancer and HIV-AIDS.